Combinatorial Perturbation with Multi-Omics Readout to Dissect Etiology of Alzheimer's Disease Using Stem Cell and In Vivo Models

Combinatorial Perturbation with Multi-Omics Readout to Dissect Etiology of Alzheimer's Disease Using
Stem Cell and In Vivo Models
Abstract
Alzheimer's disease (AD) is a prevalent age-related neurodegenerative disorder. While early-onset AD is
driven by well-characterized genes, the mechanistic links between aging and late-onset AD remain elusive.
Human genetic studies have revealed numerous risk alleles that modulate AD susceptibility, but their complex
interactions are challenging to study using current tools. We propose to develop Combo-Seq/Tag, a powerful
toolkit combining precisely installing multiple risk alleles (Combo-Seq) with a multiplex protein tagging tool
(Combo-Tag) for studying endogenous protein interactions. These tools will enable efficient perturbation of AD
risk genes and multi-omics readouts in human stem cell models. We will also generate a Combo-Seq/Tag
mouse strain compatible with the 5xFAD AD model for in vivo study. Our project will yield innovative products,
including multiplex, optimized gene-editing vectors, and rich multi-omics datasets, amplifying the impact of AD
human genetics studies. By providing a toolkit to dissect the complex genetic interactions underlying AD
pathogenesis, our work will contribute to understanding the mechanistic links between aging and
neurodegeneration, potentially revealing novel targets for AD diagnosis and therapy.

Public health relevance
Project Narrative Alzheimer's disease is a devastating disorder that affects millions of older adults, causing progressive memory loss, cognitive decline, and disability. Our project aims to develop innovative tools to better understand the complex genetic factors that contribute to Alzheimer's risk, particularly how they interact with each other and with the aging process. By shedding light on these mechanisms using the stem cell and in vivo model, our work has the potential to guide the development of new strategies for diagnosis and treatment of Alzheimer's disease, ultimately helping to reduce the immense burden on individuals, families, and society.